Cardiovascular Disease Epidemiology & Prevention

Health workforce projections for the United States consistently indicate a shortage of well-trained researchers in the fields of epidemiology and prevention. Importantly, the U.S. Bureau of Labor Statistics reports that the employment of epidemiologists is projected to grow 26 percent from 2021 to 2031, much faster than the average for all occupations. Meeting this surge in demand will require sustained support for training programs across the U.S. This five-year proposal is for renewal of a longstanding training grant in the epidemiology and prevention of cardiovascular disease administered by the Division of Epidemiology & Community Health, School of Public Health, University of Minnesota. The program is highly successful, having graduated 75 postdoctoral and predoctoral fellows since 1977. Among graduates in the past 15 years, 93% are currently in research positions, and 67% have obtained research funding, mostly from NIH. The training program’s excellent facilities, large and diverse faculty, and broad research opportunities offer an outstanding training environment. Our training program has continued to evolve and improve, to offer a cutting-edge training experience in cardiovascular disease epidemiology and prevention.
In the most recent period (2019-2024), the program was awarded four predoctoral and three postdoctoral fellowship positions. Positions have been filled throughout and we continue to have outstanding applicants. A total of 14 different faculty have served as a formal mentor for at least one trainee during this same time period, demonstrating the breadth of expertise available to the trainees and the extent of involvement of participating faculty in the delivery of training. Fellows have been highly productive, generating impactful publications and presenting at national and international meetings. Our proposal for renewal (2024-2029) is to maintain seven fellowship positions per year – three postdoctoral and four predoctoral.
The University of Minnesota T32 fellowship program offers outstanding training opportunities in direct research experience combined with a strong curriculum of formal coursework, seminars and expert mentorship. The uniqueness of the training is the commitment of its faculty and the breadth of existing research, from the laboratory to the community. The continued need for qualified cardiovascular epidemiologists and the program’s documented success justify its renewal.

Public health relevance
Project Narrative This University of Minnesota program will provide training in cardiovascular disease epidemiology and prevention to 3 postdoctoral and 4 predoctoral (PhD) students. Trainees will learn how to formulate and conduct research to enhance understanding of the causes of cardiovascular disease and how to prevent them.